Unraveling the role of endothelium in chemotherapy-induced cardiotoxicity

Project Summary/Abstract
Doxorubicin is a highly effective chemotherapy drug commonly used to treat multiple cancers, but its use is
limited due to cardiotoxicity. Cardiotoxicity can range from asymptomatic reduction in left ventricular ejection
fraction to highly symptomatic heart failure (Class III to IV). Acute doxorubicin-induced cardiotoxicity (DIC)
occurs in ~11% of patients, and long-term cardiotoxic side effects can develop in ~36% of patients up to 10
years after treatment. Despite being the most effective class of anti-cancer drug and widely used since last five
decades, the molecular mechanisms that underly DIC remain poorly understood. To date, three major inter-
related mechanisms for cardiotoxic effects of doxorubicin have been proposed: (i) generation of reactive
oxygen species (ROS) and subsequent membrane damage, (ii) inhibition of topoisomerase II-β (TOP2B)
topoisomerase I mitochondrial (TOP1MT), and (iii) modulation of intracellular calcium release. However, as
cardiotoxicity in DIC patients may not emerge for years or decades, a better understanding of the different
mechanisms in DIC across different cardiac cell types and their crosstalk can have significant implications on
the search for therapeutics.
The endothelium is a critical component of the cardiovascular system that forms a protective barrier for CMs
and releases paracrine factors to maintain CM health and function. It has been shown that DOX disrupts the
normal endothelial physiology by damaging ECs that can lead to the development of severe chronic vascular
diseases such as atherosclerosis, which often leads to cardiac dysfunction. With the knowledge that
dysfunctional ECs can have a negative impact on CM function, we need a better understanding of the integral
role of ECs in the development of doxorubicin-induced myocardial injury. Despite impressive progress, little
attention has been given to the potential importance of cell-to-cell signaling between ECs and CMs, despite the
fact that ECs serve a paracrine function to enhance signaling in CMs, especially in context to pharmacological
stimulation. This knowledge gap impedes our comprehensive understanding of organ dysfunction at a multi-
cellular level. The overarching goal of our proposal is to use a multidisciplinary approach that integrates human
iPSCs, bioengineering tools, and NGS to gain novel insights into the pathogenesis of DIC. We will pursue three
specific aims. In Aim 1: we will establish an experimental platform to study the role of ECs in DIC. For this, we
will recapitulate the EC-CM crosstalk in DIC patient’s iPSC-derived cells with 3D engineered heart tissues
(EHTs). In Aim 2: we will decipher the mechanism of EC-CM crosstalk in EHTs treated with DOX using single-
cell approaches (scRNA-seq and scATAC-seq). In Aim 3: we will validate the key regulatory players of EC-CM
crosstalk in an animal model of DIC. Our proposal is supported by compelling preliminary data from a multi-
disciplinary team of investigators. We believe we are well positioned to achieve the project goals within five
years.

Public health relevance
Project Narrative The emergence of induced pluripotent stem cell (iPSC) technology offers an experimental human-based platform to predict and model chemotherapy-induced cardiotoxicity. The goal of this project is to study the role of the endothelium in the pathogenesis of doxorubicin-induced cardiotoxicity using bioengineering tools and next generation sequencing. Results from this work could potentially lead to new strategies that could lower morbidity and mortality, but also improve the management of cardiotoxicity patients.